Antimicrobial resistant E. coli before and after California Senate bill 27 (ARES): a natural experiment

ABSTRACT Overuse of antibiotics contributes to antimicrobial resistance (AMR) and is a growing threat to human health worldwide. In the U.S., industrial food animal production (IFAP) is a powerful driver of antibiotic use. Seventy percent of antibiotics are sold for use in livestock, including tetracycline, gentamicin, and third-generation cephalosporins (3GC). In an attempt to reduce AMR and population health impacts, beginning January 1, 2018, California's Senate Bill 27 (SB27) will ban all non-therapeutic uses of antimicrobials in livestock (includ- ing growth promotion and routine disease prevention) and require a veterinarian's prescription for therapeutic indications. We will quantify the effect of this legislation on AMR E. coli E. coli is an ideal pathogen for evaluating changes in antimicrobial use and AMR related to livestock production because (1) AMR profiles of E. coli circulating in livestock and humans overlap; and (2) extraintestinal pathogenic E. coli are a leading cause of human UTI, which cost Americans $1-2 billion annually. We plan to use data ranging from the molecular to the population level in a natural exper- iment to address three specific aims. In Aim 1, we will use whole genome sequencing and antimicrobial sus- ceptibility testing to characterize resistance genes, phenotypes, and E. coli populations isolated from retail chicken meat and UTI. We hypothesize that contaminated retail meat products contribute to the burden of AMR E. coli UTI in humans. In Aim 2, we will leverage longitudinal (2015-2021) electronic health records on retail chicken meat and human E. coli urinary tract infections (UTIs). (EHRs) on more than 7 million outpatients with 100,000 E. coli UTIs per year from two major California health systems to estimate longitudinal changes in the proportion of tetracycline-, gentamicin-, and 3GC-resistant E. coli isolated from retail chicken meat and laboratory-confirmed E. coli UTI before and after the implementation of SB27. We will also employ synthetic control statistical analyses to estimate the causal effect of SB27 on AMR trends in retail chicken meat and E. coli UTI. We anticipate that the enactment of SB27 will be associated with reductions in AMR of E. coli isolated from retail chicken meat and human UTI cases. In Aim 3, we will conduct spatial analyses using patient addresses from EHRs and IFAP location data. We hypothesize that pri- or to SB27, residential proximity to IFAP will be a risk factor for tetracycline-, gentamicin-, and 3GC-resistant E. coli UTI; after SB27, this risk will be reduced. The approach is innovative because it uses a quasi-experimental design built around a first-in-the U.S. policy-mandated reduction in livestock antimicrobial use. Results of this work will make a significant contribution to the evidence base connecting food systems and UTI and will de- termine if this state-level legislative intervention affects AMR trends in retail meat and human UTIs, informing decision-making about implementation of similar policies across the U.S.

Public health relevance
PROJECT NARRATIVE On January 1, 2018, California will enact a Senate Bill (SB27), making it the first state in the U.S. to ban non- therapeutic antimicrobial use in livestock production. This measure, designed to curb overuse of antibiotics in industrial food animal production represents a singular opportunity for a natural experiment to rigorously evalu- ate the role of industrial livestock production on antimicrobial resistance in E. coli from meat-source and human infection. We will leverage whole genome sequencing and expansive electronic health record data to deter- mine whether an upstream, statewide policy to reduce antibiotic use in livestock production will have a down- stream, beneficial impact on human health.